TREM2 Genotype-Informed Drug Repurposing and Combination Therapy Design for Alzheimers Disease

PROJECT SUMMARY
The cumulative evidence indicates neuro-inflammation play crucial roles in Alzheimer’s disease (AD) and anti-
inflammatory agents (i.e., microglia-targeted therapies) show potential treatments for AD. The treatment
window for microglia-targeted therapies may at least be open later in AD due to the nature of microglial biology.
If amyloid-β is the trigger for AD, and tau is the executioner, then microglia are accelerators of disease
progression. Microglia-targeted approaches have a better chance of success in mild to moderate disease
compared to anti-amyloid therapies that have to prevent the trigger early in AD. Among the microglial genes,
triggering receptor expressed on myeloid cells 2 (TREM2) has received much attention because a hemizygous
R47H variant of TREM2 (TREM2R47H) increases the AD risk by 2-7 folds in various populations, including African
American. Our preliminary single-nucleus RNA-sequencing (snRNAseq) study identified disease-associated
microglia (DAM) with enhanced AD pro-inflammatory signatures (i.e., activation of Akt-signaling) associated with
the TREM2R47H variant and pharmacological Akt inhibition reversed the TREM2R47H induced inflammation,
showing proof-of-concept of TREM2R47H targeted drug discovery in AD. Using multimodal snRNAseq analysis,
we identified two approved anti-inflammatory asthma drugs (fluticasone and mometasone) that were predicted
to modulate DAM molecular networks are associated with a reduced incidence of AD in electronic health record
(EHR) data of 7 million patients. We therefore posit that understanding how the AD-linked mutations (i.e.,
TREM2R47H) enhance microglial toxicity could lead to understanding how microglia become maladaptive/toxic
and development of microglia-targeted therapeutic strategy for late-onset sporadic AD in general. This
application calls for novel microglia-targeted drug repurposing and combination therapies for AD using our
well-established multi-omics and deep learning-based EHR approaches, and functional observations in AD
patient-induced pluripotent stem cells (iPSCs), cerebral organoids, and mouse models, with three specific Aims.
Aim 1 will test the TREM2R47H informed microglia-targeted therapeutic hypothesis for identifying cell type-specific
molecular drivers/networks, repurposable drugs, and combination therapies for AD using multi-omics evidence
aggregation. These analyses will leverage our existing snRNAseq data (n = 24 TREM2R47H and n = 23 common
variant (CV)-TREM2 with matched age, AD pathology and APOE genotypes) and public genomic data from the
AD knowledge portal. Aim 2 will identify repurposable drugs and combination therapies using high-throughput
EHR-based hypothesis generation and sequential deep learning-based propensity score matching approaches.
We will leverage de-identified EHRs from the INSIGHT networks (~11 million patients across New York City’s 5
health systems and the greater metropolitan area). Aim 3 will screen, test and validate drugs using AD patient-
derived iPSC lines carrying TREM2R47H in conjunction with cerebral organoid and mouse models. The successful
completion of this project will offer a viable strategy to move AD drug repurposing from bench to bedside rapidly.
1

Public health relevance
Project Narrative Alzheimer’s disease (AD), a devastating neurodegenerative disease, is estimated that 13.8 million Americans and 90 million people worldwide will be affected by 2050, without disease-modifying treatments. This project will develop capable and intelligent computer-based network medicine, electronic health record (EHRs), and multimodal single-nucleus genomic analytic tools along with functional validation using AD patient-induced pluripotent stem cells (iPSC) and iPSC-derived cerebral organoid and TREM2R47H knock-in mouse models for identifying TREM2 genotype-informed microglia-targeted therapeutics for AD. The successful completion of this project will identify novel aspects of the underlying immune mechanisms in TREM2R47H mutant AD human brains, leading to potential repurposable drugs and combination therapies to be tested in AD clinical trials directly. 1